Core A - Admin Core

CORE A- SUMMARY/ABSTRACT
The administrative Core (Core A) will provide all the necessary administrative support and coordination to the
Project Leaders, Core leaders, and all investigators and researchers involved in the studies to successfully
accomplish their set scientific goals. Therefore, Core A will be critical for the overall success of this Program
Project. This success will rely vitally on its support in organizing the scientific and administrative aspects of each
Project, and all the interactions amongst the members and the Cores. Core A will be responsible for managing
the interaction amongst all members of the PPG as a whole and all the necessary conferences and meetings
among the Project and Core Leaders to facilitate data generation, integration, and, importantly, maintaining the
highest level of synergy between the projects. It will provide critical logistical support for highly important tasks,
such as grant renewals, budgetary issues, adherence to rules and regulations of the involved institutions and the
National Institutes of Health (NIH), and submission of abstracts and manuscripts. Finally, Core A will manage all
IRB- and IACUC-related issues surrounding human material use and animal welfare and care, respectively. Core
A will manage all financial management activities. Core A will oversee the efficient utilization of the allocated
funds, while conforming to the regulations of the associated Institutions and NIH. The duties of Core A will be
performed by the Program Manager/Administrative Assistant (Ms. Nicole Plummer), under the direction of Dr.
Tsokos, and by the Financial Manager/Grants Financial Specialist (Ms. Marilyn Tessier). Ms. Plummer will be
responsible for arranging the meetings between Leaders of Projects and Cores, the members of the Internal and
External Scientific Advisory Boards, and the investigators. She will also assist with the submission of abstracts,
manuscripts, presentations, and progress reports, as well as maintain the lines of communication between the
groups interacting in the Program. Ms. Plummer will oversee the financial management, including budget
handling, accounting and monitoring of expenditures, as well as preparation of yearly annual budgets and all
necessary budget-related documents required for renewals.

Public health relevance
PROJECT NARRATIVE – Administrative Core A Core A will be responsible for the coordination of all administrative and regulatory aspects of the proposed research.